SHINING A LIGHT ON BAT CELLULAR IMMUNITY FOLLOWING VIRUS INFECTION

Project summary/abstract
Bats are important reservoir hosts for a variety of viruses, several of which are associated with fatality rates as
high as 90% among diagnosed human cases. This includes the highly pathogenic henipaviruses, of which
Hendra virus (HeV) emerged in Australia and Nipah virus (NiV) in South-east Asia via horse and pig
intermediate hosts respectively. The henipaviruses have been shown to be transmitted from Pteropus bats,
with the Australian black flying fox (Pteropus alecto) confirmed as a reservoir for HeV (1, 2). As with other viral
infections in bats, natural or experimental infection of bats with HeV causes no clinical signs of disease despite
shedding of virus. The antiviral immune response of P. alecto is among the most well studied of all bat species,
with novel immune mechanisms already discovered including the constitutive expression of interferon alpha
discovered by our team (3). These characteristics make the P. alecto – HeV model uniquely suited to
answering the questions we propose in this project. Despite the increasing emergence of zoonotic viruses from
bats, studies of bat immunology remain in their infancy and few studies have examined the adaptive immune
responses of any bat species. Understanding the antiviral responses in bats is crucial if we are to predict and
prevent virus spillover from bats to other susceptible species, understand disease pathogenesis in other
mammals and uncover new therapeutics and vaccines to treat these diseases in humans and other animals.
In this study, we will characterise the innate and adaptive immune response of experimentally infected bats to
HeV to obtain detailed insights into how bats control viral infection. The cell mediated immune response of bats
will be dissected using functional assays to determine the subsets of cells activated during an active infection
and explore global gene and protein expression to characterise the innate and adaptive immune response of
infected bats. The use of innovative approaches to identify MHC bound HeV peptides in infected bats, building
on previous bat immunopeptidomics studies, will provide new insights into peptide presentation during
infection. Few studies have comprehensively studied the immune response of bats during infection, and none
have examined the functional activation of the cell mediated immune response. Comparison with infected
ferrets will allow us to directly compare mechanisms responsible for innocuous (bats) compared to fatal
(ferrets) HeV infection. Expected outcomes include understanding the basic biology of antiviral responses in
bats and the development of new tools to monitor bat immunity to HeV and related viruses.
The Australian Centre for Disease Preparedness and Monash University are uniquely suited for performing the
work outlined in this proposal with a strong track record of working together on bat immunology. The team has
access to high containment facilities and expertise to perform animal infections with dangerous pathogens
combined with access to protein chemistry facilities and expertise in generating tetramer reagents.

Public health relevance
Project narrative Bats are natural reservoirs to a variety of viruses, many of which are highly pathogenic in humans and other species, including HeV which has a mortality rate of up to 90% in humans. Although the immune response of P. alecto to HeV is among the most well studied of all viral infections in bats, information on the cell mediated immune response in any bat species is still scant and few studies have comprehensively studied the immune response of bats through the course of an infection. The goals of this project are to perform an in-depth analysis of the immune response to HeV in experimentally infected bats to understand the interplay between the innate and adaptive immune response in controlling viral infection.